Statistical analysis of large genomic data sets

Project Summary/Abstract
Alzheimer's disease (AD) is a highly heritable, common and fatal neurodegenerative disease
among older people. There have been significant advances in genomic studies of risk factors,
volumetric variations of the human brain and AD, however, there is a lack of systemic analysis of
these traits together. Single trait analysis is not only less powerful than multiple trait analysis in
searching for disease associated variants but also misses the opportunity to identify novel
pleiotropic variants and to understand the biological mechanism among them. Since risk factors
and brain function and structure all contribute to AD, an AD polygenic risk score incorporating
genetic components obtained from risk factors and brain imaging data may substantially improve
its. But how to incorporate this information has not been studied. Furthermore, searching for rare
variants contributing to AD is extremely challenged and requires a large sample size. Novel
analysis approaches are necessary to improve the identification of AD associated rare variants.
Our NHGRI funded project R01 HG011052 entitled “Statistical analysis of large genomic data
sets” is developing statistical methods and software for estimating causal effects among traits
and searching for pleiotropic variants, as well as testing rare variant associations by incorporating
linkage evidence and natural selection. We believe these novel methods can contribute AD
research and move the field forward. In this project we propose two specific aims using the
methods and software we developed in HG011052. In Aim 1, we will construct a genetic network,
identify genetic variants with and without pleiotropy effects and construct a composite polygenic
risk score for AD. In Aim 2, we will identify rare genetic variants associated with AD by
incorporating family information and natural selection. Our proposed work focuses on
understanding the mechanism of AD and the project HG011052 is the foundation of this
administrative supplement.

Public health relevance
Project Narrative Alzheimer's disease (AD) is a highly heritable, common and fatal neurodegenerative disease that currently affects over 5 million Americans. Many putative risk factors potentially contribute to the risk of AD. Brain imaging traits obtained from magnetic resonance imaging has been connected with AD. This study will using existing GWAS summary statistics, whole genome sequencing and whole exome sequencing data and AD individual level data to 1) construct a genetic network, identify genetic variants with and without pleiotropy effects and construct a composite polygenic risk score for AD; 2) identify rare genetic variants associated with AD by incorporating family information and natural selection.